Reversible Covalent BTK Degraders as the Next Generation Targeted Therapy to Treat B-cell Malignancies

Abstract
Bruton’s Tyrosine Kinase (BTK) is a clinically proven target to attenuate B-cell receptor (BCR) signaling in
B-cell malignancies, including mantle cell lymphoma (MCL) and chronic lymphocytic leukemia (CLL). Ibrutinib, a
first-in-class, once-daily, oral covalent BTK inhibitor was approved by the FDA to treat relapsed/refractory MCL
in 2013 based on the multiple-center Phase II clinical trial led by Dr. Michael Wang (multi-PI on this application).
Although ibrutinib has been successful in treating MCL and CLL, acquired resistance arises quickly, mostly
through mutations in the BTK kinase domain to significantly reduce ibrutinib efficacy in CLL and the activation of
alternative survival pathways in MCL. Additionally, disrupting kinase function of BTK using kinase inhibitors is
the only currently available therapeutic intervention on this well-validated target. However, BTK can also enhance
antigen receptor-induced calcium influx in a kinase-independent manner, while a kinase inactive BTK mutant
can partially rescue B cell development of BTK-null B cells in mice. In this project, we will develop a small
molecule therapeutic agent that can efficiently inhibit and degrade BTK in cells irrespective of BTK mutation
status to abolish both BTK kinase and non-kinase activities completely. In our preliminary studies, we developed
RC-1 as the first reversible covalent chemistry-based BTK degrader. Based on our highly promising preliminary
studies, extensive expertise in drug development, and clinical expertise in MCL and CLL, we hypothesize that
further optimization of RC-1 will lead to a next-generation targeted therapy for MCL, CLL and other B-cell
malignances and significantly improve treatment outcomes. To achieve this goal, we have assembled a highly
motivated team with complementary expertise. Dr. J. Wang is an expert in chemical biology and drug discovery.
His previous work led to the development of the first-in-class inhibitor for steroid receptor coactivators, which is
under commercialization. His laboratory has established the full pipeline for drug discovery, including organic
synthesis, in vitro assays, ADMET profiling and preclinical efficacy testing. Dr. M. Wang (MD Anderson) and Dr.
Woyach (Ohio State) are leading physician scientists in lymphoma research, specializing in the BTK signaling
pathway. Dr. M Wang’s clinical studies led to the FDA approval of two BTK inhibitors, ibrutinib and acalabrutinib.
Dr. Woyach is a leader in ibrutinib-resistant mechanisms. In this project, we will further optimize BTK degraders
with drug-like properties and test the therapeutic efficacies in MCL and CLL mouse models. In our and others’
studies, BTK degraders can be more potent than inhibitors in certain B cell malignancies. This novel mechanism
of action for BTK targeting has never been explored in the clinic. We expect that successful completion of this
project will make a significant impact on the treatments of B-cell malignancies.

Public health relevance
Narrative Drug resistance is the main problem to treat mantle cell lymphoma (MCL) and chronic lymphocytic leukemia (CLL). We will develop a novel targeted therapy to treat MCL and CLL. We expect that successful completion of this project will make a significant impact on the treatments of B-cell malignancies.